Cell & Tissue Imaging and Data Science Core

PROJECT SUMMARY: CELL & TISSUE IMAGING AND DATA SCIENCE CORE
The Cell & Tissue Imaging and Data Science Core will enhance the activities and accomplishments of ongoing
research projects by providing histology services, access to a range of advanced imaging equipment, and
technical expertise for image analysis and implementation of artificial intelligence (AI) approaches. It will
provide essential resources for microscopic evaluation of ocular tissues and extraction of biological data from
images, thereby increasing the innovative capabilities of participating investigators for conducting productive
vision research. The Core will provide equipment and technical expertise for performing histology,
light/confocal and electron microscopy, live cell imaging, image analysis, and development/application of AI
algorithms. The specific aims are to provide resources for: 1) performing histology of ocular tissue specimens;
2) enabling investigators to evaluate ocular tissues with the use of sophisticated light/confocal and electron
microscopy and emerging imaging modalities; 3) training investigators and their research staff on the utility and
operation of imaging equipment; 4) consultations on cell and tissue preparation and imaging for experimental
design and appropriateness of techniques; 5) providing expertise and technical support for image analysis and
development of AI methodologies.